Vaper to Vaper (V2V): A Multimodal Mobile Peer Driven Intervention to Support Adolescents in Quitting Vaping

7. Project Summary/Abstract
The FDA and the US Surgeon General call the increasing use of e-cigarettes among U.S. adolescents an
epidemic, with e-cigarette use exceeding combustible cigarette use. The high amounts of nicotine in e-cigarettes
harm adolescent brain development, impacting learning, memory, and attention. Adolescent e-cigarette users
also are at higher risk than non-users of transitioning to traditional cigarettes. While prevention is important,
evidence-based interventions to engage and help adolescent e-cigarette users quit are critically needed. Key
challenges include adolescents perceiving e-cigarette use to be of low risk resulting in a low intention to quit,
and the major influence of peers in e-cigarette use. Given there currently are no evidence-based cessation
interventions to assist adolescent e-cigarette users in quitting, as suggested by the American Academy of
Pediatrics and FDA, we propose to develop Vaper-to-Vaper (V2V), a multi-modal mobile peer driven intervention,
based on lessons learned in our prior tobacco intervention work. Peer-driven interventions have been found to
successfully improve smoking outcomes in adolescents, and we have had success in developing peer-driven
interventions for low motivated adult smokers. We therefore will adapt these approaches for adolescent e-
cigarette users. V2V’s goal will be to engage, educate, motivate, and facilitate the adolescent in using strategies
to manage cravings and successfully quit. The V2V components will include: Peer Messaging (tailored messages
pushed via texting), Peer Coaching (asynchronous communications with trained coaches via texting), and
Gamification (using game design to motivate participation). Adapting these tools to the unique needs of
adolescent e-cigarette users will further extend these tools into novel directions. For Aim 1 we will convene a
peer advisory panel of 20 adolescent e-cigarette users to participate in a qualitative assessment and further
development of V2V components. In Aim 2 we will evaluate the feasibility of the research protocols and the
feasibility and acceptability of the V2V intervention in a pilot feasibility study with eighty adolescent e-cigarette
users from 4 high schools (schools randomized to either V2V intervention or control) recruited and followed for
6 months. We hypothesize being able to recruit 80 adolescents (20/school, 40 per study condition) and that
>85% will be retained in each study condition at 6-month follow-up (Aim 2A). For Aim 2b we will monitor V2V
engagement (e.g., number of V2V texting quizzes completed, peer coaching interactions, peer videos viewed)
and assess acceptability of and satisfaction with the program. For Aim 2C we hypothesize that the intervention
will be associated with greater cotinine-validated 7-day point prevalence vaping abstinence rates, lower time to
first quit attempt, and less amount of e-cigarette use compared to control at 6-month follow-up. This Stage I
project, adapting an existing intervention and feasibility/pilot testing, will provide the necessary materials and
information to proceed to a subsequent large-scale Stage III R01 trial to test the efficacy of the V2V intervention
in supporting adolescent e-cigarette users in quitting.

Public health relevance
8. Narrative The dramatic increase in the use of e-cigarettes among U.S. adolescents has been called a national epidemic, with more adolescents now using e-cigarettes than traditional cigarettes. The high amounts of nicotine in e- cigarettes harm adolescents and put them at greater risk of becoming traditional cigarette smokers. We propose to develop Vaper-to-Vaper (V2V), a suite of mobile peer driven tools including peer texting and coaching based on lessons learned in our prior tobacco intervention work, to engage and help adolescents use strategies to manage cravings and successfully quit.